Core 2 - ARSC

ABSTRACT – CORE 002: Adolescent Research Support Core
Conducting adolescent tobacco use research is inherently complex and logistically challenging. Researchers
must address complex issues with informed assent and parental consent, while considering stakeholder
interest in the dissemination of study findings when the research involves youth-serving organizations, such as
schools. Project MARVEL consists of a partnership with a large school district and four innovative projects
involving research with adolescent participants. A critical component in MARVEL’s implementation is
successfully facilitating the proposed research with a large number of adolescents from multiple schools and
maintaining participant engagement across projects over time. Addressing these implementation areas is the
focus of the Adolescent Research Support Core (ARSC). ARSC’s mission is to provide a centralized
infrastructure grounded in best practices for adolescent research, with input from stakeholders, to help each
project address the complexities associated with conducting adolescent research. This core will oversee the
critical functions of recruitment, enrollment, and retention for each project, facilitate participant confidentiality,
provide health and well-being resources for participants, and translate scientific findings into lay language for
non-academic audiences. The ARSC will use evidence-based approaches, such as community engagement,
to establish two advisory boards, one comprised of adolescents and one of key stakeholders. The boards will
provide input on school engagement, recruitment and retention of adolescent participants, participant
confidentiality, and translation of scientific findings. School engagement will be centrally managed by ARSC
and will include collaborating with a point-person at each high school to inform parents/guardians and students
about MARVEL; coordinating the implementation of two district-wide, in-class screener surveys; and
centralizing the process for obtaining district-level approvals for conducting the studies. The ARSC will
organize adolescent recruitment, enrollment, and retention activities. Importantly, the ARSC will implement
procedures to ensure protection of participant confidentiality and identify and address emotional and behavioral
concerns, if they arise during data collection. To maximize data collection efficiency and quality, the ARSC will
manage a team of study coordinators, allocated across projects based on project needs. Each laboratory
participant will be paired with a coordinator to provide a consistent point-person to minimize attrition. The
ARSC, led by a strong, multi-disciplinary team with extensive experience conducting research with adolescents
in schools and other community and laboratory settings, is a critical component of Project MARVEL. The
ARSC will collaborate with the other Cores to fully support the four research projects, coordinating essential
services to maximize efficiency while engaging community stakeholders and centrally managing school
engagement and the recruitment and retention of adolescent research participants.

Public health relevance
NARRATIVE – CORE 002: Adolescent Research Support Core Research on adolescent vaping is critical for developing and testing evidence-based prevention efforts that target population-level changes. However, such research is challenging, as it involves a vulnerable population with many stakeholder interests to consider. The Adolescent Research Support Core will support Project MARVEL’s four integrated research projects by providing efficient procedures, informed by community partners, to facilitate recruitment, retention, and dissemination of findings, while ensuring the protection of adolescent participants.